Network-based Framework to Decode Novel ÃÂ¢ÃÂÃÂGain-of-FunctionÃÂ¢ÃÂÃÂ Mutations and their Mechanistic Roles in General Human Diseases

Traditionally, disease causal mutations were thought to disrupt gene function. However, it becomes
more and more clear that many deleterious mutations could exhibit a 'gain-of-function' behavior.
Systematic investigation of such mutations has been lacking and largely overlooked. In the last few
years it has become more clear that the efficacy and specificity of signal transduction in a cell
is, at heart, a problem of molecular recognition and protein interaction. In distinct cell
types (with varying genotypes), precise signal transduction controls cell decision,
including gene regulation and phenotypic output. When signal transduction goes awry due to gain-of-
function mutations, it would give rise to various disease types. Research in my
laboratory is focused on developing and utilizing quantitative and molecular technologies to
understand protein interaction networks and their perturbations by genomic mutations, bridging
genotype and phenotype in health and disease. Our overall goal is to contribute to the
understanding of disease mechanisms and of more open ended questions about explanations
for 'missing heritability' in genome-wide association studies. We envision that
It will be instrumental to push current human genetics research paradigm towards a thorough
functional and quantitative modeling of all genomic mutations and their mechanistic
molecular interaction events involved in disease development and progression. Therefore,
gaining a systems-level understanding of gain-of-function mutations requires to resolve the
plastic nature of molecular interactions, and to integrate experimental and
computational strategies at the genome scale. Many fundamental questions pertaining to
genotype-phenotype relationships remain unresolved. For example, how do interaction
networks undergo rewiring upon gain-of- function mutations? Which mutations are key for gene
regulation and cellular decisions? Do mutagtions exhit allel-specific behaviors or how do the
allelic combinations work to coordinate cellular phenotypes? Is it possible to leverage molecular
interaction networks to engineer signal transduction in cells, aiming to cure disease? To begin to
address these questions, in this proposal, we will systematically interrogate of gain-of-function
disease mutations using a novel network-based systems biology framework. We will then decipher
condition-dependent protein-protein interaction perturbations induced by gain-of-function
mutations in disorder regions and phosphorylation sites. Finally, we will determine
allele-specific and allele-combinatorial effect of gain-of-function mutations on protein
interaction network rewiring. Together, this integrative proposal is innovative because
it will provide insights in prioritizing driver functional gain-of-function
disease mutations, and uncovering individualized molecular mechanisms at a base resolution.
Furthermore, it is significant because it will greatly facilitate the functional annotation
of a large number of gain-of-function mutations, providing a fundamental link between
genotype and phenotype in general human disease.

Public health relevance
Although disease causal mutations were traditionally thought to disrupt gene function, it becomes increasingly appreciated that many deleterious mutations could exhibit a 'gain-of-function' behavior. Current knowledge and technologies that could identify such mutations and their functional consequences across diverse human diseases are fragmentary and extremely limited, and have been gleaned entirely from a handful of pathological examples. This proposal describes a set of innovative projects to broadly discover and characterize gain-of-function genomic aberrations that influence protein activities that regulate information flow in cellular signaling networks, and lessons learned will provide much needed insight into disease mechanisms and how they can be modulated for therapeutic benefit.